Mapping deep evolutionary divergences in cellular models of stress response

SUMMARY
Understanding how nature builds new traits is a fundamental goal of evolutionary genetics. Unbiased
experimental dissection of trait variation from the wild has to date used linkage or association mapping, which
are suitable only for crosses between compatible individuals of a given species. In the first funding period of
this methods-development R01, PI Brem developed RH-seq, an approach for the unbiased mapping of natural
trait variation that can be applied to reproductively isolated species. Our RH-seq projects in invertebrate test
cases have put the complex genetics of ancient traits within reach for the first time in the experimental
literature. We now want to advance strategies that investigate deeper themes in complex genetics between
species—namely whether evolution uses concerted molecular mechanisms across the loci underlying a
polygenic adaptation, and how these loci work together to drive phenotype. To test-drive these approaches, in
our first Aim we will use an ecologically relevant model system, a thermotolerance divergence between yeast
species that last shared an ancestor five million years ago. In our second Aim, we will port our ideas and tools
for interspecies genetics to mouse primary cells. The latter will use as a testbed a cell-autonomous, pro-
inflammatory aging program called cellular senescence, which we have found to diverge between between
sister species of mice. We will develop RH-seq for unbiased genetic mapping of senescence traits, and we will
pursue epistatic and molecular mechanisms of the underlying loci as a parallel to our yeast model. Together,
our yeast and mouse projects will advance methods for the analysis of polygenic traits as they differ between
species, and accelerate the dissection of such ancient characters in systems across Eukarya.

Public health relevance
NARRATIVE Many characters of interest in biomedicine evolved long ago and are fixed in a particular species, distinguishing it from unaffected relatives; finding the genes underlying any such ancient trait has been a central challenge in the field. We have developed a method, RH-seq, for genetic dissection of interspecies trait variation, and applied it in invertebrate models. We now propose to study how species-defining alleles confer their effects, alone and together, in a yeast model system, and we propose to port our approaches for interspecies genetics to mouse cells, with a focus on cellular senescence.